Deciphering the Role of Aberrant Endogenous Retroviral Expression in Onco-histone Driven Glioma

ABSTRACT
The polycomb repressive complex 2 (PRC2) is recurrently disrupted in brain cancer; a complex required for
depositing the repressive histone modification, H3K27 tri-methylation (H3K27me3). Maintenance of PRC2
function is important for repression of genes and repetitive elements, providing a safe-guard against aberrant
transcription. PRC2 is essential for proper embryonic cell maintenance, neural stem cell differentiation, and
overall brain development. How PRC2 dysfunction and aberrant H3K27me3 levels contributes to brain
tumorigenesis is unclear. As a model of PRC2 dysfunction in brain tumors, our lab investigates midline high
grade gliomas (HGG) that harbor frequent histone H3 lysine 27 to methionine mutations (denoted H3K27M).
Expression of H3K27M impairs PRC2 function and results in a global loss of H3K27me3; a defining feature of
these brain tumors. Using isogenic glioma models in which H3K27M is deleted, we found that the H3K27M
results in a global increase in a mark of active transcription, H3K27 acetylation (H3K27ac) (Krug et al., Cancer
Cell, 2019). Surprisingly, global H3K27ac has minimal effects on gene transcription. Instead, we discovered a
novel mechanism of H3K27ac associated transcription of repetitive DNA elements, namely Type-H human
endogenous retroviral (HERV) sequences. We hypothesize that: 1) HERV activation plays a functional role in
the biology of H3K27M-driven glioma, and 2) Amplification of HERV expression represents a novel anti-cancer
strategy against tumors with global loss of H3K27me3. To test this hypothesis we propose three specific aims
to: 1) Decipher the mechanisms of HERV transcriptional activation in H3K27M-driven glioma, 2) Determine the
impact of HERV expression on H3K27M-glioma cell identity and tumor formation, and 3) Delineate the
mechanisms of HERV detection and response in H3K27M-glioma. Collectively these experiments will reveal
mechanistic insight into the role of HERV expression in high-grade glioma and cellular vulnerabilities created by
H3K27M mutations.

Public health relevance
NARRATIVE This study will delineate the role of endogenous retroviral expression (ERV) in high grade glioma which are driven by the H3K27M mutation. We will explore mechanisms of ERV activation, expression, and detection towards defining points of cellular vulnerabilities as new therapeutic strategies.